New Technology for In Vivo Monitoring the Brain Extracellular Proteome at High Spatial Resolution in Substance Abuse Models

Project Summary.
The overall objective of this project is to develop novel approaches to sample, identify, and quantify
proteins secreted into the brain extracellular space in relation to substance use disorders (SUD). The
progression to compulsive drug consumption is associated with changes in neuronal structure and
neurotransmitter release in response to drugs. Evidence suggests that proteins in the extracellular space play
a role in these changes. For example, brain derived neurotrophic factor (BDNF) released to the extracellular
space may stimulate neuronal changes that are associated with adaptation to drugs of abuse; however,
practically no direct measures of proteins in the brain extracellular space have been made. The ability to track
release of certain neurotransmitters in vivo has dramatically advanced over the past 2 decades and led to
profound increases in our understanding of how their release is altered by and contributes to SUD. Opening a
window onto how proteins dynamically change will provide even greater insights. A powerful approach to
monitoring is in vivo sampling coupled to analytical techniques. This approach, exemplified by microdialysis
sampling, has been instrumental in uncovering dynamics of dopamine and other small molecules in brain
function and substance abuse. This method has been less successful for tracking proteins due to low
recoveries of these molecules. Low recovery is due to low diffusion of proteins to the sampling device and
adsorption to dialysis membranes. Such probes are also too large to sample many brain nuclei. Here we
describe novel sampling systems that will have higher recovery for proteins at spatial resolution that is 1000-
fold better than microdialysis. We will develop a new sampling method that induces electrically driven flow
through the brain to drive proteins into a sampling capillary. This electroosmotic push-pull perfusion (EOPPP)
probe will be tested for its ability to recover proteins. The effectiveness of this method will be compared to
another new probe based on low-flow push-pull perfusion. In this method, a microfabricated probe, tens of
micrometers in width and thickness, has a single channel to withdraw sample and a second to deliver
replacement fluid at ~100 nL/min.
After testing and development of these sampling probes, we will then develop proteomic methods to
analyze the extracellular proteome. These methods will be based on microscale sample preparation to digest
proteins to component peptides, advanced high-resolution separation of peptides, and state-of-the art
proteomic analysis by mass spectrometry and informatics. We will identify extracellular proteins in the nucleus
accumbens and prefrontal cortex for the first time. We will then compare the extracellular proteome in controls
to that found in animals trained to self-administer cocaine, a validated model of SUD. This work will uncover
new neural substrates of SUD and set the stage for further exploration of the brain proteome in SUD models.
.

Public health relevance
Public Health Relevance. Substance use disorders comprise some of the most devastating and expensive to treat disorders in modern society. Determining the neurochemical imbalances underlying such disorders is a key step in developing appropriate therapies; however, in most cases the neurochemistry, especially of extracellular proteins, is not well understood. In this project, we are developing novel instrumentation and techniques that enable proteins to be monitored in the living brain and testing them in an animal model of cocaine use.